Gene Targeting Core

The primary goal of the Gene Targeting core will be to make available to the investigators of individual projects all available expertise, facilities, techniques and technical support required for generating /-/p/ttargeted mice, knockout/knockin mice and BAC transgenics. In addition, the core will provide reagents and advice on how to construct plasmids for use in Hprt targeting. In the case of knockout/knockin and BAC transgenic approaches, the core will also provide technical expertise in constructing targeting vectors.

Public health relevance
The overall significance of Core C is that it will greatly facilitate the in vivo study of promoter function in the endothelium